Defining Phenotypes of Alcohol-Associated Liver Disease with Acute Hepatic Decompensation

Project Summary
Alcohol consumption and mortality due to alcohol-associated liver disease (ALD) are increasing in the United
States, and ALD is now the leading cause of liver transplantation. The natural history of ALD is distinct from
other etiologies of liver disease, with more advanced disease at the time of presentation but also opportunity
for hepatic recovery. Accurate prediction of outcome remains challenging. The proposed research will establish
a prospective registry and biorepository that will evaluate the outcomes of patients with ALD and alcohol use
disorder who are hospitalized with acute hepatic decompensation. This study will take a multifaceted approach,
considering the biologic and psychosocial influences on clinical outcomes. Patients will be recruited during
hospitalization and followed for 2 years in the outpatient clinics, with longitudinal measures of alcohol use
patterns, serum biomarkers, radiographic features, nutrition, frailty/sarcopenia, and non-invasive assessments
of fibrosis, inflammation, and steatosis. Specific Aims: (1) Characterize the cohort and optimize retention
procedures using frequent communication, collateral contacts, and technology-based resources, (2) Identify
distinct trajectories of ALD using latent class trajectory analysis and the predictors of trajectory classification,
and (3) Develop a patient-specific risk prediction model to predict hepatic recovery after an acute hepatic
decompensation. These project aims will identify distinct phenotypes and predictors of outcome in ALD and
improve prognostication to better target interventions and allocate resources. The principal investigator (PI) is a
hepatologist and clinical researcher at Stanford University, with a long-term vision of improving care for
patients with ALD. Her experience with outcomes research and her Master’s in Clinical Research and
Epidemiology have prepared her well to execute the project aims. The proposed research and career
development plan are well-supported by a multi-disciplinary mentorship team and the institution. The PI will
acquire advanced skills in longitudinal data analysis and machine learning, as well as content expertise in
alcohol research, which will allow her to apply advanced statistical techniques to optimize prediction of
outcome in ALD in a clinically relevant context. In addition, she will have a well-characterized ALD registry and
biorepository to serve as a platform for future translational and multicenter studies. This award will provide the
PI with the protected time, mentorship, training, and research experience to develop an independent research
career in ALD and improve our understanding of this serious and prevalent condition.

Public health relevance
Project Narrative Alcohol-associated liver disease represents a growing public health burden, particularly among younger age groups, women, and ethnic minorities, and is now the leading cause of liver transplantation in the United States. This project will identify predictors of outcome and improve prognostication in severely ill patients with alcohol- associated liver disease. Identifying reliable non-invasive markers that characterize the distinct phenotypes of alcohol-associated liver disease will be crucial to advance our understanding of this liver disease, target interventions, and appropriately allocate resources including liver transplantation.